Incucyte SX5 Live-Cell Analysis System

Project Summary
Recent progress in cell imaging and molecular fluorescent tags has provided opportunities to
perform a wide variety of cell-based assays using cell imagers. Experiments that previously
required fluorescent microscopes on a slide-by-slide basis can now be run in a high through-put
format up to 384 samples at a time and quantified using new algorithms and software which saves
time and resources. In the St. Mary's University Biology department, all students take the Cell
and Molecular Methods laboratory course during their sophomore year to introduce them to
advanced biological techniques such as cell imaging and cell-based assays. Previous assays
have been performed using our fluorescent microscopes but were time-consuming and were
limited by the number of microscopes available. Here, we propose that the Incucyte SX5 Live-
Cell Analysis system will provide advanced, high throughput, and more variety of cell-based
assays. It Is a versatile imaging system that combines bright field and fluorescent channels for
comprehensive whole-well live-cell imaging. Its advanced software package allows for accurate
data quantification and analysis, supporting various biological assays such as apoptosis, cell
cycle, and cytotoxicity. Operating within a standard tissue culture incubator, it maintains precise
environmental control, enabling uninterrupted incubation and simultaneous imaging of up to six
microplates. The user-friendly software facilitates experiment setup, visual inspection, and the
generation of publication-ready graphs. Additionally, it provides fluorescence calibration,
seamless networked access, and ample data storage capacity for efficient data management.
This imaging system would provide an opportunity for our researchers and students involved in a
variety of biology areas to perform advanced high-throughput experiments. In this proposal, we
outline biology faculty that would utilize the instrument in their research and teaching labs.
Additionally, future collaborations with other departments including engineering, chemistry, and
environmental science may find this imager useful as well. Furthermore, this system will provide
our faculty with a powerful tool to generate high-quality data, facilitating the preparation of future
NIH-funded grant proposals and driving the advancement of biomedical research on our campus.
Aligned with our mission, commitment to diversity, and dedication to excellence in teaching and
research, the addition of a live cell imager at St. Mary's University represents a significant step
forward in advancing cutting-edge research in biology and STEM fields. Empowering our faculty
and students with state-of-the-art technology will enable us to make substantial contributions to
the scientific community and shape the future of biomedical research.

Public health relevance
Project Narrative The proposed Incucyte SX5 Live-Cell Analysis System at St. Mary's University not only addresses the limitations of traditional fluorescent microscopes but also provides students with access to exciting new technology. By utilizing this state-of-the-art instrument for high-throughput cell-based assays, students will have the opportunity to engage with cutting-edge techniques and technologies, igniting their interest and passion for science careers. This invaluable experience will broaden their perspective on scientific research, inspiring them to pursue a future dedicated to scientific exploration and innovation.